Research Training Center for Botanicals and Chronic Diseases in Tajikistan and Indonesia

This renewal will build on a successful research training program carried out in Tajikistan during the last
five years. We will leverage accumulated expertise, training materials, networks of international collaborators,
and well-developed and tested online and face-to-face training curricula to expand the Tajikistan program and
to add Indonesia to the program. Close collaborations between US, Tajik and Indonesian faculty involved in this
proposal are well-established and fully functional. The expanded Center for Botanicals and Chronic Diseases
(CBCD) will cement and synergize these existing collaborations and provide quality international experience for
our trainees. In the next five years, CBCD will focus its training on the evidence-based, rigorous studies of local
botanicals for the prevention and treatment of common inflammation-associated chronic diseases and disorders,
such as diabetes and metabolic syndrome, cardiovascular diseases, osteo- and rheumatoid arthritis, and
intestinal and neurological disorders.
CBCD will train 10 scientists in Tajikistan (5 Ph.D. students and 5 postdoctoral fellows) and 24 scientists
in Indonesia (16 M.S. and 8 Ph.D. students). Both countries are providing a significant financial match to enable
the training. Research training components will include: 1) Online courses and e-workshops; 2) One-on-one e-
mentoring and progress monitoring; 3) Annual in-country conferences and workshops with invited international
speakers; 4) Visits to mentor's laboratories in the US (funded by Tajikistan for Tajik students); and 5) Required
graduate and postdoctoral courses offered in partnering countries.
CBCD will involve three U.S. institutions - Rutgers University, Pennington Biomedical Research
Center/Louisiana State University, and Eugenio María de Hostos Community College (CUNY), a minority serving
institution specializing in health-related training. Internationally, CBCD will involve three leading Tajik institutions
and two top-tier Indonesian universities. In addition to its official trainees, CBCD will open its distance learning
courses, on-line training and in-country events to a wider audience of local scientists and health professionals,
ensuring a broader community outreach.
CBCD’s aim is to provide a sustainable foundation for intense research training and retention of local
scientists in the interdisciplinary studies of botanicals for the prevention and treatment of chronic diseases. Our
integrated training program will leverage resources generated through other NIH-funded programs that involve
the research training faculty participating in this proposal: NIH National Center for Botanicals and Metabolic
Resiliency (2004 – present); NIH T32 Training Grant in Botanical Approaches to Combat Metabolic Syndrome
(just renewed for a 5 year third cycle) and the completed International Cooperative Biodiversity Groups (ICBG)
program titled “Building New Pharmaceutical Capabilities in Central Asia.” CBCD will also take advantage of the
world-wide research training infrastructure established by the Global Institute for Bioexploration (GIBEX).

Public health relevance
This renewal project will enable Tajikistan and Indonesia to provide the in-country research training on botanicals for prevention and treatment of chronic diseases, such as diabetes, rheumatoid and osteoarthritis and digestive and neurological disorders. Extensive online and face-to-face training curriculum will be coordinated by the Center for Botanicals and Chronic Diseases (CBCD). CBCD will train 10 scientists in Tajikistan and 24 scientists in Indonesia, thus contributing to improved public health and medical research in both countries.